Human Gastrointestinal Biomimetics for Enteric Viral Infections

PROJECT SUMMARY
Gastroenteritis (GE) is among the leading causes of mortality globally. Our research focuses on human rotavirus
(HRV) and human norovirus (HuNoV), the two leading causes of viral GE worldwide causing over 320,000
deaths annually. No antivirals are available for either virus and there is no vaccine for HuNoVs. While vaccines
to HRV are available and are effective in high-income countries (84-90%), the efficacy remains suboptimal (45-
57%) in low-income settings where the burden of disease is greatest. Economically, HuNoV infections result in
over $4 billion in direct healthcare costs and over $60 billion in societal costs each year. These data underscore
the need for continued investment in studies to overcome mucosal enteric disease.
Both these human GI viruses do not infect mice; further, HRV replicates poorly in cultured cells, and HuNoV was
noncultivatable for over almost 50 years. Using tissue stem cell-derived human intestinal organoid (HIO) cultures
as a replication model for these human GI pathogens, we made some remarkable fundamental discoveries. Key
findings include: both human viruses replicate in at least two distinct intestinal cell types (enterocytes and
enterendocrine cells) in the small intestine, and HRVs also replicate in the colon. Each virus binds to genetically
encoded histo-blood antigens (HBGAs) but these glycans play different roles in infection. HBGA expression does
not restrict infection but correlates with severe HRV disease while it is required for infection with HuNoV.
Interactions with HBGA are strain-dependent for both viruses. Each virus infects the polarized epithelium by a
different route with HRVs infecting basolaterally and HuNoVs infecting apically. Infected HIO cultures produce a
new form of HRV released in vesicles that exhibit different properties from standard cell-culture derived virus.
Both viruses induce a predominant epithelial innate response of type III interferon (IFN); surprisingly this does
not restrict virus replication suggesting type III IFN may have other functions than being antiviral. HIOs allow
cultivation of multiple HuNoV strains and bile is a critical factor for replication.
Although these previous studies using epithelial-only HIOs provide new knowledge on HRV and HuNoV
infections, we still lack a comprehensive understanding of the pathophysiology and host responses that lead to
life-threatening disease. Continued development of “human mini-gut” models is required to fully understand
human-GI virus interactions linked to pathogenesis and improve mucosal immune responses to viral infections.
Using complex biomimetic cultures, we propose to answer two biological questions of fundamental and clinical
relevance: What mechanisms mediate severe GI disease during infection with HRV and HuNoV (Aim 1), and
what is the role of microbe-microbe interactions in the pathophysiology of viral GE (Aim 2)? Through interactions
with Projects 2 and 3 and our two Scientific Cores, we predict our studies will advance and enable human
organ biomimetics as translational models to understand human mucosal infections and to serve as a bridge
between preclinical animal models and first-in-human clinical trials.